Diversity Supplement to Structural Dynamics of Cardiac Myosin-Binding Protein C Regulation

Title of project: DIVERSITY SUPPLEMENT TO STRUCTURAL DYNAMICS OF CARDIAC MYOSIN-BINDING PROTEIN C REGULATION. Myosin-binding protein C (MyBP-C) plays a major role in the modulation of cardiac function by its phosphorylation and causes deficits in contractile function due to MyBP-C mutations in hypertrophic cardiomyopathy (HCM) and reduced phosphorylation in heart failure. Our goal is to understand the molecular biophysics of muscle, with particular emphasis on the heart, and to train the next generation of muscle biophysicists, inclusive of diverse trainees. The parent research project and diversity supplement ask fundamental questions about the role of protein interactions and structural dynamics that regulate function in cardiac muscle. To gain insight into the correlation of structure-function involved in MyBP-C mechanisms in physiological and pathological settings, we will probe the actin-myosin-MyBP-C complex of these proteins in solution with varied binding, phosphorylation, and HCM mutations. Our core technology is site-directed spectroscopy, applied to purified MyBP-C and actin/myosin filaments. We will apply innovative complementary methods in site-directed labeling and spectroscopy to correlate protein binding, structural dynamics and function. We will test the central hypothesis that phosphorylation and HCM mutations of N-terminal MyBP-C alter functionally significant structural properties of MyBP-C alone and as it interacts with actin and myosin. Related to parent grant Aim 1, the first period of the diversity supplement focuses on using spectroscopic approaches to accurately measure the structural dynamics within M-domain of purified MyBP-C, where phosphorylation occurs, primarily by measuring nanometer distances and molecular disorder. Major emphasis is placed on detection of conformational changes (structure) within MyBP-C’s M-domain due to phosphorylation, HCM mutation, and actin or myosin binding (function). By including the location of probes in M-domain, the Candidate will measure structural changes predicted from our computational simulations. Fluorescently-labeled MyBP-C will be prepared to acquire fluorescence lifetime using time-resolved methods. In the second period, the Candidate will learn new skills in spectroscopic data fitting analysis to determine probe-to-probe distances and disorder in N-terminal MyBP-C. The third period will contribute to both Aim 1 and Aim 2 by providing molecular details of the structural dynamics of the actin-MyBP-C complex with added troponin, tropomyosin, and myosin to mimic physiological conditions of the cardiac thin filament in muscle. The Candidate will systematically build in model system complexity, from actin-bound to thin filament-bound MyBP-C, with low (diastole) or high (systole) activator Ca2+, and upon binding of cardiac myosin, providing key insights at the myofilament level to be applied for understanding fundamental mechanisms in the muscle cell. Spectroscopic study of MyBP-C regulation of thin filaments will determine protein interactions and structural dynamics. This project is grounded in fundamental biophysics mechanisms, but MyBP-C has emerged as a therapeutic target for cardiac disease. Thus, of our work lays a foundation for development of screens for drug therapies using our unique spectroscopic approaches.

Public health relevance
PROJECT NARRATIVE We aim to determine the molecular requirements for healthy cardiac muscle function, to pave the way for discovery and design of more effective therapies for heart disease. Our work will answer crucial questions about how the protein myosin-binding protein C (MyBP-C), the leading cause of cardiomyopathy, functions in the heart, using reporter probes to visualize dynamic protein structures in healthy, stressed, and diseased mutant protein complexes. This research will greatly improve the human health prospects for understanding disease by determining effects of disease mutations and will develop tools that can be used to discover novel treatments and provide training and career development for the next generation of diverse muscle biophysicists.